DelineateQSP: Accelerating Quantitative Systems Pharmacology Model Building and Repurposing

Delineate Inc.’s proposed STTR Phase I project aims to develop an innovative platform that
uses Large Language Models (LLMs) to accelerate the building and repurposing of Quantitative
Systems Pharmacology (QSP) models from scientific literature. QSP involves the creation of
mechanistic models that can de-risk the drug development process, improve clinical trial
outcomes, and aid in the smarter design of novel treatments but the process of constructing
models is heavily bottlenecked which currently limits their scientific impact. Through this project,
Delineate Inc. in partnership with the Julia lab at MIT, aim to validate the use of LLMs and other
AI methods to overcome the challenges modelers face when building models, such as efficiently
extracting literature data and repurposing models for new use cases. The project has three main
objectives: (1) develop an LLM-powered platform for efficient QSP model construction from
literature, (2) validate the platform by building test QSP models and conducting time studies to
demonstrate a significant reduction in model building time, and (3) enable model provenance
tracking and prediction of invalid assumptions for accurate model repurposing. The successful
completion of this project will lay the foundation for a commercially viable solution that can
greatly improve the efficiency of the QSP model building process and accelerate the
development of new life-saving therapeutics.

Public health relevance
Delineate's innovative platform aims to revolutionize the process of building and repurposing Quantitative Systems Pharmacology (QSP) models, mechanistic mathematical models that can be used to investigate the mechanism of action of therapeutics at different scales, thereby improving safety and efficacy of drugs. By accelerating the construction of these models and removing barriers to their accurate reuse in new contexts, Delineate aims to increase their use across the entire drug development pipeline. Increased use of QSP models in informing key development decisions will reduce the risk of costly drug failures and improve patient outcomes.